Uncovering the two-partner secretion mechanism and novel antimicrobials

Pertussis is a re-emerging public health concern, and its resurgence is correlated with a switch from whole-cell
to acellular vaccines, which prevent disease, but not colonization or transmission of the causative agent
Bordetella pertussis. In order to limit the mortality and morbidity associated with pertussis, particularly in infants,
a combination of more effective vaccines and antibiotic therapies are needed. Their development requires a
better understanding of the molecular basis for Bordetella pertussis pathogenicity. We are proposing
experiments that will answer longstanding questions regarding the secretory mechanism of Filamentous
hemagglutinin (FhaB), a critical virulence factor for Bordetella pertussis and to identify peptides which
inhibit FhaB secretion.
FhaB mediates adherence to mammalian respiratory epithelial cells, suppresses the inflammatory response and
is required for Bordetella to persist in the murine respiratory tract. FhaB is a TpsA protein secreted by the TpsB
protein FhaC. FhaBC are the model for two-partner secretion (TPS) systems. TPS systems are broadly
distributed among Gram-negative bacteria and many have proven or postulated roles in virulence.
TpsB proteins are part of the Omp85 superfamily which also includes outer membrane protein assembly factors
such BamA. Due to the complex topology and large size of FhaB and other TpsA effectors, no structures of
active TpsB transporters in complex with their effectors have been solved. The lack of structural information has
limited our understanding of how TpsB proteins interact with TpsA passengers and complicates the design of
effective anti-microbials targeting these systems.
We propose to: 1) Determine the mechanism and structure of the early stages of FhaB secretion by FhaC using
a simplified FhaB/FhaC system that we have developed in E. coli and 2) screen a large library (>1012) of cyclic
peptides to identify those that bind and inhibit FhaC.
This is a collaborative project that takes advantage of the expertise and resources of the Cotter and Doyle
laboratories. The results of this work will lay the foundation for a substantial collaboration between the two groups
investigating the molecular basis for the TPS mechanism and identification of antimicrobial compounds targeting
these systems in Gram negative pathogens.

Public health relevance
This project combines the expertise of the Cotter and Doyle laboratories to determine the first structure of the Bordetella TpsB transporter (FhaC) in complex with its cognate passenger (FhaB) and to identify novel compounds that inhibit TpsB transporters. To date structural information is limited to individual structures of FhaC and FhaB which provide limited information about how TpsB proteins secrete their passengers. TpsB transporters play key roles in the pathogenesis of important Gram-negative pathogens and TpsB inhibitors have the potential to act as both targeted and broad-spectrum anti-virulence agents.